ULTRAVIOLET RAMAN STUDIES OF PROTEINS AND NUCLEIC ACIDS

This project seeks to understand the molecular dynamics of the allosteric transition in hemoglobin, using spectroscopic probes of protein structure to investigate the change from low- to high-affinity states. These states control the hemoglobin function in healthy and diseased states. Their understanding is also critical for the development of hemoglobin-based blood substitutes. The spectroscopic techniques to be applied to hemoglobin are ultraviolet resonance Raman spectroscopy, and Fourier transform infrared spectroscopy. Both will be used in a time-resolved mode to generate spectra of transient states of the protein, and thereby provide structural mapping of the allosteric reaction coordinate.